Neurocognitive markers of short-term risk for suicidal behavior in high-risk Veterans

Project Summary/Abstract
Given the high rates of Veteran suicide each year, suicide prevention has become a VHA strategic
priority. While progress has been made in screening Veterans for suicide risk, high rates of false positives
remain a challenge, potentially diverting clinical resources away from those Veterans who need them most.
Innovative new approaches to assess suicide risk are needed, that accurately identify short-term (e.g. coming
weeks) risk of suicidal behavior, and that are based on objective markers rather than relying primarily on self-
report. Recent work has identified several cognitive domains, including impulse control and inhibition,
increased distractibility, implicit semantic content, and processing of rewards/punishments, that may all be
altered in suicidal individuals.
The current project will use a battery of computer-based tests to assess these cognitive domains,
followed by computational modeling to extract additional meta-variables representing latent cognitive
processes, to prospectively predict short-term risk of suicidal behavior in high-risk Veterans. Veterans
will be recruited from acute in-patient psychiatric units following a suicidal event, and tested at 3-month
intervals for a year; we will also record suicidal behavior (SB), defined as an actual, interrupted, or aborted
attempt or a behavior preparatory to suicide. In Aim 1, we will use neurocognitive task scores collected shortly
before the SB, to determine which tasks (and therefore, alterations in which cognitive domains) can
prospectively predict short-term risk of SB (within the next 3 months). In Aim 2, we will conduct computational
modeling on the behavioral data, to extract additional meta-variables, describing latent cognitive processes
such as response caution (impulsivity); subjective value of rewarding, punishing, and neutral feedback;
perseveration; and tendency to explore new responses, to determine which of these meta-variables can
prospectively predict SB. In Aim 3, we will combine these neurocognitive task scores and meta-variables,
along with "standard" indicators of suicide risk such as demographic, self-report, and clinical assessment, in a
statistical prediction model, to determine whether inclusion of these cognitive variables and meta-variables can
significantly improve prediction of short-term risk for SB in this high-risk Veteran sample.
The results of this study will provide much-needed information to improve identification of Veterans
likely to make a suicide attempt in the upcoming weeks, so that clinical resources can be targeted to help
them. The computer-based neurocognitive tests represent relatively objective behavioral markers that could be
deployed fairly simply in a clinical setting or even via telehealth. Additionally, our focus on underlying cognitive
processes, as modifiable factors, will improve the ability to optimize intervention by suggesting specific
therapeutic approaches based on an individual Veteran's cognitive profile.

Public health relevance
Project Narrative/Health Relevance About 5,000 Veterans take their own lives each year. While the VA has currently mandated a multifaceted prevention approach, including suicide risk screening of all Veterans seen for mental health issues, the continued large numbers of Veterans who attempt or die of suicide points to the desperate need for improved prediction of suicide risk. Existing prediction methods are subject to high rates of false alarm, so that only about 10% of Veterans flagged as at-risk actually attempt suicide; this high false alarm rate potentially diffuses critical clinical resources away from those who need them most. The development of more accurate predictive tools has been identified as one of the most important areas in suicide research, and would also improve the evidence base for clinical therapy, by more accurately identifying at-risk clients to participate in research trials and evaluating treatment effectiveness across time.